Molecular and Epigenetic Mechanisms of Hereditary Hearing Loss

In FY25 the GCBC continued to generate IsoSeq data from mouse tissue and single-cell preparations of cochlea; nuclei isolated from human post-mortem cochleae and microdissections of chicken basilar papillae. The annotation of novel RNA splice isoforms, as well as abundance profiles of all RNA splice isoforms, is being shared with NIDCD intramural investigators as tracks that are uploadable to public genome browsers. The annotation is being prepared for sharing with the extramural community via gEAR, and a publication describing the annotation is being prepared with an extramural collaborator. A publication describing a mouse model that exhibits differential gene expression, as well as differential splice isoform expression, between mutants and wild-type mice has been accepted for publication and a preprint is currently available in bioRxiv (Nakano et al. 2025; PMID: 40631138).